Pilot Projects Core

The purpose of the SHIMR Pilot Project Core is to support investigators with novel ideas or technologies relevant to the priority research topics in human immunology in the RFA-AI-09-040. These small grants will provide funds to obtain pilot data as a foundation for subsequent application for extramural funding. The specific aims of this Core are: 1 A. to solicit pilot project proposals on an annual basis within the Stanford research community, 1 .B. to review these proposals and to forward requests for funding for 1-3 projects/year to the Steering Committee, 1 .C. to provide infrastructure support for the Pilot Projects during the award period, and 1 .D. to monitor the progress of the Pilot Projects on a quarterly basis as well as the overall success of the program by tracking publications and extramural funding obtained on the basis of these awards.

Public health relevance
RELEVANCE (See instructions): We wish to analyze different disease/vaccine models in order to define common and unique characterstics of responder and non-responder individuals. We will develop new informative tools and assays that should illuminate specific questions regarding these study groups and will also be of benefit generally with respect to